Novel animal models to study miRNA-mediated alcoholic liver disease

PROJECT SUMMARY
This application is in response to the funding opportunity “Alcoholic hepatitis clinical and translational
network – basic and preclinical research (RFA-AA-18-006) under UH2/UH3 funding mechanism”. The
goals of our application are to stimulate innovative basic/pre-clinical research to facilitate our
understanding on the role of miR-21 in AH. We propose an exploratory yet novel approach to generate
animal model targeting cell-type specific miR-21 in the liver. As a proof of concept to support our
approach, we have generated hepatocyte specific miR-21-/- mice. Using the loss of function approach,
we found, for the first time the connection between miR-21 and lipid metabolism, that hepatocyte miR-
21-/- mice are more sensitive to hepatic steatosis after alcohol feeding. As part of UH2 phase (Yrs 1
and 2), we will further explore the phenotypes of hepatocyte miR-21-/- mice in response to alcohol
feeding and also propose to assess the feasibility of creating two new experimental animal models by
generating KC-specific and HSC-specific miR-21-/- mice, respectively. As one of the goals of this
funding mechanism, our proposal during the UH2 phase will lead to a breakthrough in the development
of animal models specifically targeting miR-21 that could have a major impact on AH field. The
success of the study during the UH2 phase will lead us to the UH3 validation phase to further explore
the in-depth mechanistic study on the role of miR-21 in AH (Yrs 3-5) and to translate the understanding
of the basic molecular mechanism by integrating our data into the AH network patient-oriented research
setting to further determine the prognostic significance of miR-21 in patients with AH (Yrs 4-5).

Public health relevance
PROJECT NARRATIVE Alcoholic liver disease (ALD) is a major cause of chronic liver diseases in the United States, which ranges from steatosis to cirrhosis. The goals of our application are to stimulate innovative basic/pre- clinical research to facilitate our understanding on the role of miR-21 in animal model of ALD by generating animal model targeting cell-type specific miR-21 in the liver and to translate the understanding of the basic molecular mechanism by integrating our data into the AH network patient- oriented research to further determine the prognostic significance of miR-21 in patients with AH.